Molecular mechanisms governing the ubiquitination signaling during KSHV cell entry and tumorigenesis

Infection with Kaposi sarcoma herpesvirus (KSHV) has been shown to increase the risk of classic Kaposi's
sarcoma (KS), AIDS-associated KS (AIDS-KS) and lymphoproliferative disorders, including primary effusion
lymphoma (PEL) and multicentric Castleman disease (MCD) in HIV/AIDS. About 30-40% of AIDS-related
cancers in HIV+ individuals treated with antiretroviral drugs are caused due to KSHV infection, and in many
circumstances they are incurable. Emerging studies have indicated that chronic inflammation mediated by
transcription factors, including STAT3 and NF-κB, in KSHV-infected cells plays critical role in the development
of KSHV-associated malignancies in HIV (+) individuals. Protein ubiquitination, a post-translational modification,
plays key roles in the regulation of NF-κB and STAT3 activation, pathogenic virus entry into target cells, and
survival of virus infected cells. Using an unbiased Ubi-Scan proteomics approach, we have identified tumor
specific CADM1 ubiquitination at lysine 437 (K437), which is essential for chronic activation of STAT3 and NF-
κB and the proliferation and survival of PEL cells. CADM1-K63-Ubi is also critical for efficient KSHV entry into
target cells after KSHV de novo infection. Using siRNA library-based screening we identified the E2 ubiquitin
conjugating enzyme Ubc13 and the E3 ubiquitin ligase Mib1, as essential factors for CADM1 ubiquitination. In
addition, we found that ubiquitinated CADM1 was required for the activation of the small GTPase Rac1 in KSHV-
infected cells, which in turn was critical for chronic STAT3 and NF-κB activation and PEL cell proliferation and
survival. Furthermore, using siRNA library-based screening of Guanine nucleotide exchange factors (GEFs), we
have also determined that the GEF TIAM1 is required for Rac1 activation. Therefore, we hypothesize that KSHV
de novo infection-induced rapid Ubc13 and Mib1-dependent CADM1-K63 ubiquitination leads to the activation
of TIAM1/Rac1 and NF-κB and STAT3 essential for KSHV entry into target cells, KSHV latency establishment
and KSHV lymphoma cells survival and proliferation. To test this hypothesis, we propose three specific Aims: 1)
Mechanistic roles of CADM1-K63-Ubi and its associated molecules in KSHV entry into target cells after de novo
infection, 2) Mechanistic roles of CADM1-K63-Ubi and its associated molecules in NF-κB and STAT3 activation
after KSHV de novo infection, and 3) Examine the efficacy of small molecule inhibitors against CADM1-K63-Ubi
and its associated molecules using PEL patient-derived xenograft (PDX) mouse model. Data obtained from this
project will reveal the mechanisms of chronic STAT3 and NF-κB activation and efficient KSHV entry into target
cells after KSHV de novo infection. These findings will pave the way for therapeutic intervention of KSHV-
mediated highly aggressive AIDS associated malignancies, which are often seen throughout the US, particularly
South Florida, which has one of the highest incidences of HIV in the country.

Public health relevance
PROJECT NARRATIVE Persistent activation of NF-κB and STAT3 leading to chronic induction of inflammation and survival factors is a critical mechanism for the development of KSHV-associated cancers in HIV+ individuals treated with antiretroviral drugs. The focus of this proposal is to determine the mechanistic roles of the host factors involved in STAT3 and NF-κB activation and KSHV entry into target cells after KSHV de novo infection. We will substantiate our findings in vivo via a KSHV-tumor xenograft model and elucidate the efficacy of pharmacological drug targets for the cellular factors."